PARTIAL SUPPORT FOR THE CORE ACTIVITIES OF THE GOVERNMENT-UNIVERSITY-INDUSTRY RESEARCH ROUNDTABLE (GUIRR)

The Government-University-Industry Research Roundtable, within the Policy and Global Affairs Division of the National Academies, is charged with improving the research enterprise of the United States by successfully resolving the cross-sectoral issues that prevent the U.S. research enterprise from reaching its full potential. This mission is achieved by convening senior-most representatives from government, universities, and industry to frame the critical issues, followed – when appropriate – by the execution of activities designed to address specific cross-sectoral impediments to achieving a healthy, vibrant research enterprise. GUIRR provides a unique forum for dialogue among top government, university and industry leaders of the national science and technology enterprise.

Public health relevance
Public Health Relevance: